Flow Cytometry Core Facility

Highlights from the NHLBI Flow Cytometry Core (August 01, 2024, to July 31st, 2025):

1)- Provided cell sorting, cytometry, immunoassay and assay specific training & consulting services (9009 hours of services) to 98 PIs; NHLBI (n=44), NIDDK (n=21) and Other NIH ICs (33), while maintaining state-of-the-art facility and implementing new technologies.
2)- Operating two 24/7 cell analysis sites, one located in the CRC (3-5217, 5225 & 5209) and other in Bldg. 10 section (RN: 8C104), for analytical flow cytometry. The CRC section also provides 24/7, self-operable cell sorting for trained users.
3)- Core provided 495.25 non-revenue hours of training and consulting services for enabling path to independence to core users.
4) Core organized two-day hands-on workshop on Imaging Flow cytometry for NHLBI Flow cytometry core users.
5)- Core achieved 119% of cost recovery target of FY25.
6)- Yielded 20 publications during FY 24 reporting period.

Overview of the NHLBI Flow Cytometry Core Facility
Mission statement. The mission of the NHLBI Flow Cytometry Core Facility, established in 2001, is to provide cutting edge services in cell sorting and advanced analytical cytometry to the NHLBI Division of Intramural Research and, by way of a memorandum of understanding (MOU), to NIDDK, NEI, NICHD and NINDS. These objectives are achieved by acquiring, maintaining, and operating state-of-the-art instrumentation and establishing the expertise required to provide investigators with the resources necessary to accomplish their research goals. Please visit https://www.nhlbi.nih.gov/science/flow-cytometry-core and https://intranet.nhlbi.nih.gov/laboratories-and-core-facilities/flow-cytometry-core for detailed information about science, services and policies of the core facility.

Technical expertise, services, and responsibilities. The Flow Cytometry Core has exceptional expertise in flow cytometry and immunoassays. The staff has over 70 years of combined experience in flow cytometry, including experimental design, data interpretation, quality control and set up of complex instrumentation, as well as the advanced analysis of high dimensional flow cytometry data. Services include a broad range of flow cytometric and immunologic assays. The Core Facility staff ensures the optimal operation of all instruments, assists investigators in planning and interpreting experiments, trains users to operate instrumentation and perform cytometric assays, and assists in preparing figures and methods descriptions for manuscripts. Key card access for availing analytical cytometry services on a 24/7 basis is provided to trained users. The staff is also responsible for all safety requirements, inventory of supplies, scheduling, billing, and continuing education as needed. More information about services and instrumentation can be explored at: https://intranet.nhlbi.nih.gov/laboratories-and-core-facilities/flow-cytometry-core.